Readying the commercialization of Omega device as an improved safe and efficacious treatment for drug-failed GERD patients

Project Summary/Abstract
GERD is a chronic condition that impacts 784M people worldwide by decreasing quality of life and potentially
leading to serious complications. For the estimated 157 million worldwide GERD patients whose drug
managements are not working or are leading to serious side effects (drug-failed), the only option is surgery,
where a partial or full fundoplication is the gold standard. This treatment, though, is morbid and difficult and is
reserved as a last resort. Aplos Medical's solution, Omega PF (Ω PF), is a novel therapeutic strategy for drug-
failed patients, and the only treatment that replicates the one-way valve function of the Lower Esophageal
Sphincter, allowing food to pass easily while preventing stomach acid from entering the esophagus. Early
clinical results show that the Ω PF device is simple, effective, and safe (SES), and the only treatment in 80+
years that has all these three SES elements. It is also the only treatment that recreates the natural sphincter's
one-way valve. Ω PF resolves patients' GERD without adverse events. Its simple laparoscopic procedure
allows easy adoption by all foregut surgeons worldwide, and not limited to a few experts. The success of this
early clinical outcome warrants the start to fulfill the many other requirements besides the clinical study
necessary to commercialize Ω PF. The goal of this SBIR CRP research is to perform commercialization
activities to successfully bring Ω PF to market. These include accomplishing the following Aims: (Aim 1)
Optimize Introducer Design to Accommodate Human Anatomy, (Aim 2) Develop Quality Management System
(QMS), (Aim 3) Develop Pivotal, Regulatory, Reimbursement, and Pricing Strategy, and (Aim 4) Develop an
Intellectual Property Strategy. Completion of these aims will place the company in a position to successfully
manufacture devices for the pivotal trial, secure reimbursement, and build the foundation with Key Opinion
Leaders to support the go-to-market strategy for Ω PF as the logical treatment option for drug-failed GERD
patients.

Public health relevance
Project Narrative For GERD patients whose drug managements are not working or are leading to serious side effects (drug- failed), the only treatment option is surgery, where a partial or full fundoplication is the gold standard; however, this treatment is morbid and difficult and is reserved as a last resort. The proposed Omega PF will be the first safe, effective, simple treatment for drug-failed GERD patients, possibly becoming the new gold standard. This SBIR CRP research will help to fulfill requirements needed to commercialize this device.